Genetic analysis of the Dutch Hunger Winter Families Study to Boost Rigor and Robustness for Testing In-Utero Famine Effects on Aging-Related Health Conditions and Biological Aging

SUMMARY
The graying global population makes interventions to extend healthy lifespan a public heath priority. Health
insults during the perinatal period are linked with risk for aging-related health conditions, including obesity, type
2 diabetes, and cardio-metabolic disease. If these associations are causal, interventions to prevent perinatal
insults and to reverse their biological damage could delay disease onset and prolong healthspan. However,
establishing causal long-term health effects of perinatal insults in humans is challenging. Randomized trials
would be unethical. Observational studies can be biased by confounding factors that erroneously suggest a
link between insults in the perinatal period and later health. In contrast, natural experiments can isolate the
impact of perinatal insults on adult disease and healthspan. The Dutch Hunger Winter Families Study
(DHWFS) uses a sudden, war-induced famine as a natural experiment. The famine was caused by a Nazi
blockade during WWII in 1944-45. Because the impact of famine was immediate, transient, and population-
wide, DHWFS comparison of infants born during the famine with those born before or after the famine will
identify potential long-term effects of perinatal-insults. However, famine natural-experiment studies, including
DHWFS, may be vulnerable to selection bias. Birth rates decline significantly during famine; famine’s impact on
fertility and fetal/infant survival might bias famine studies of perinatal insult’s long-term effects in unknown
ways. To fill this gap in knowledge, we will genotype stored DHWFS biospecimens from of N=956 individuals,
37% of whom were exposed to famine in-utero and the remainder of whom are siblings of the famine-exposed
individuals and “time controls” born immediately before or after the famine. We will link new genetic data with
participants’ existing clinical and cognitive tests and blood DNA methylation data. We will examine in this
integrative multi-omics database the potential impact of selective fertility and fetal/infant survival during the
famine on (i) genome wide genetic characteristics; (ii) differences in polygenic risk scores for specific aging-
related health conditions; and (iii) differences in methylation quantitative trait loci (mQTL) genotypes. We will
then conduct genetics-informed analysis of famine effects on obesity, type-2 diabetes, cognitive reserve, and
epigenetic aging. Using these new resources, we will prepare an integrated multi-omics database of the
DHWFS population for use by outside research teams and generate a one of a kind resource for famine and
perinatal insult research. The proposed project will generate a new knowledge base to further examine
biological pathways that are likely to connect perinatal events to adult health and aging through genetic and
epigenetic mechanisms.

Public health relevance
NARRATIVE We will conduct new genetic assays of stored biospecimens from the Dutch Hunger Winter Families Study (DHWFS). This is needed to further examine the long-term impact of famine at the time of birth on the development of chronic disease in later life accounting for selective fertility and fetal mortality. Using the famine as a model, the study will significantly increase understanding of how perinatal insults affect health in aging, opening new avenues for intervention to prevent and reverse damage caused by perinatal insult. !